Novel Combination Product with Activity Against MRSA, MDR-Enterics and Pseudomonas

? DESCRIPTION (provided by applicant): This 2-year Phase I SBIR Application centers on completing the lead optimization of an ultra-broad-spectrum carbapenem (UBSC) lead series with an unprecedented antibacterial spectrum of activity including MRSA, Enterobacteriaceae and Pseudomonas aeruginosa. At the completion of lead optimization, the resulting Preclinical Development Candidate will be paired with a proprietary in-house ß-lactamase inhibitor (BLI) to protect against resistance by Ambler Class A, B and D carbapenemase-producing Gram negatives. Further advancement through IND-enabling preclinical studies will be proposed in the Phase II SBIR stage. Ultimately, it is envisioned that this new combination product will provide a unique clinical option for empiric therapy of multi-drug resistant polymicrobial infections in the hospital general ward and ICU, and as a second line therapy for susceptible organisms.

Public health relevance
PUBLIC HEALTH RELEVANCE: We are optimizing to 1st Preclinical Candidate a class of ultra-broad spectrum carbapenems with activity that extends to MRSA, Enterobacteriaceae and Pseudomonas aeruginosa. The compounds are being paired with a proprietary ß-lactamase inhibitor with activity that extends to all Ambler classes of carbapenemases. The combination would represent a powerful new single-treatment option against problematic, multi-drug resistant pathogens.